Kentucky BIRCWH Program: Training the Next Generation of Women's Health Scholars

The University of Kentucky’s (UK) BIRCWH program is built around three pillars: mentoring,
interdisciplinary research, and career development. Given the significant health challenges in
Kentucky, we focus on three areas of important health disparity for Appalachian Kentuckians: 1)
substance use, 2) violence against women, and 3) lifespan changes in health with aging. UK
BIRCWH objectives are: 1) to provide the environment, mentorship, and facilities to enhance
the ability of BIRCWH scholars to compete for NIH research grants in diverse areas of women’s
health research, 2) to deepen our understanding of the unique role of sex and gender in the
manifestation of health and disease, 3) to develop and implement new communication and
social networking technologies to address sex and gender differences and improve women’s
health, 4) to personalize prevention, diagnostics, and therapeutics to address health disparities,
5) to stimulate new collaborations in focused, interdisciplinary, and interactive research areas
that are essential for uncovering sex and gender differences and improving women’s health; and
6) to use a thematic multidisciplinary focus as a platform for enhancing translational research
between basic, clinical and public health scientists. Our formal framework for ‘growing the next
generation’ of women’s health and sex differences researchers includes a mentoring team for
each Scholar composed of: 1) experienced faculty members (Mentors) and 2) a former BIRCWH
scholar (Coach). This mentoring team will collectively provide in-depth research experiences
and didactic training to assistant professor, tenure-track faculty. Career development will also
include mechanisms for accountability for manuscript submissions, workshops on grant
development, and aspects of academic development such as personnel management, negotiation
skills, self-care, and promotion. UK BIRCWH Scholar appointments will be 2 years for PhD and
3 years for MD scholars. Based on our prior experience, we anticipate training 8 scholars over 5
years of funding. Outcomes: Since 2000, 40 Scholars have completed BIRCWH training (17
MDs, 23 PhDs), who have produced 1,712 peer-reviewed publications, secured $41,636,782 in
NIH funding as PI, and $239,982,415 as Co-I or PI from other external sources. UK has retained
57% of our BIRCWH graduates who continue active research programs, and support BIRCWH
as Coaches and Mentors. Given this success, why should UK’s BIRCWH funding continue?
Succinctly, Kentucky’s need continues. Our rates of substance use, violence, and chronic disease
(3 foci) are among this nation’s highest. With BIRCWH funding, we can support those who will
address the health inequities Kentuckians and others across the nation still face.

Public health relevance
NARRATIVE: Finding and addressing sex and gender differences in effective health care research and treatment are critical actions toward the goal of improving the health and wellbeing of all Americans. To achieve this goal, the UK BIRCWH seeks to continue training and supporting our next generation of academic researchers to recognize sex and gender differences in conditions that disproportionately affect Kentuckians. In this training and mentoring program for emerging researchers, we focus on 3 health concerns that disproportionately affect Appalachian Kentuckians: Substance use, violence against women, and lifespan changes.